Predoctoral Training Program in Genetics

PROGRAM SUMMARY
The Interdisciplinary Graduate Program in Genetics at the University of Iowa has a 45-year history of training
PhD students in Genetics, with 174 graduates in that time. The program currently serves 74 faculty and 42
students in four colleges and 17 academic departments across our campus. Students receive training in rigor
and reproducibility and research conduct throughout the span of their educational training. Students align with
either the standard curriculum in foundational genetics or elect to pursue the Computational Genetics (CG)
subtrack, which trains students in the biological aspects of Genetics and sophisticated computational
approaches for the analysis of large sets of genomic and genetic data. Research opportunities in both tracks
span the spectrum of Genetics, from bacterial to model organism to human genetics, from developmental
genetics to evolution, and from epigenetics and genomics to cell biology and disease mechanisms. Students
complete the program equipped have a broad range of careers in contemporary science.
Our mission is to develop a diverse pool of well-trained Geneticists and Bioinformaticists with the technical,
operational, and professional skills necessary to conduct rigorous and reproducible research safely and
responsibly, and transition into careers in the biomedical research workforce. We recognize the power of
diverse perspectives of faculty and students across the breadth of the discipline of genetics, recruited from
diverse regional, educational and ethnic backgrounds. Specifically, we propose to 1) develop and sharpen the
skills of our trainees in scientific logic and communication, 2) provide broad technical and operational training
across the multiple facets of the genetics discipline, interfacing with many areas of biology, medicine and data
science, 3) enhance diversity in the program and in the field through recruitment, retention and training for
excellence, and 4) establish a culture of mentorship through mentor training education and activity.
The training program will accomplish these goals through a solid core curriculum with additional flexibility to
enhance training in specific areas. Trainees will receive integrated training in writing skills, data analysis,
rigorous experimental design and critical thinking. They will also develop individual career plans guided by
mentors and informed by opportunities to interact with alumni and other experts from a variety of career paths.
Through teaching assistantships and opportunities to present their work at the program retreat, regional and
national conferences, they will enhance their communication skills, supplemented by formal instruction in these
areas. The program will emphasize mentor training for trainers, with mentor training opportunities for trainees.
Support is requested for 7 trainees per year, each trainee for 1 or 2 years in years 2 or 3 of their training.

Public health relevance
Project Narrative The purpose of the Predoctoral Training Program in Genetics is to optimally prepare students in their PhD training in Genetics, to meet the challenging problems of genetics, genomics, bioinformatics and personal medicine, and to become leaders in the direction of new trends in Genetics research. Our mission for society is to generate scientists that can be at the forefront of Genetics research, who can in turn contribute to training and collaborating with physicians and other allied health professionals, and who can educate all members of society, who will increasingly need to understand genetic aspects of their own family's health care and individualized genomes. Because this need is among people from all walks of life, we emphasize diversity in our PhD students; with the pervasive implications of the individualized genome, including both the promises and the dangers of exploiting the information therein, the need to train competent PhD students is paramount.